Intuitive Child Safety Seat to Increase Security

Project Summary/Abstract Minnesota HealthSolutions Corporation (MHS) proposes to develop a child safety seat with a novel intuitive single- step harness system to improve the rate of proper harnessing of children into child safety seats. Children are harnessed into child safety seats via a 5-point harness with shoulder straps that buckle at the crotch. The entire harness assembly must be properly tensioned to ensure safety. Loose harnesses are a common misuse in child safety seats. Several large studies have observed that only 10% to 20% of children are correctly harnessed into correctly installed seats. Improper use of child restraints substantially reduces their effectiveness and is a major public health concern. The proposed child safety seat will utilize a familiar and intuitive system to improve proper use of the child safety seat harness. We hypothesize that a child safety seat that provides an intuitive and easy-to- use harness system will significantly improve the rate of proper child safety seat usage and reduce vehicle crash- related child injuries and deaths. An interdisciplinary team of researchers has been assembled to define, build, and evaluate a prototype system.

Public health relevance
Project Narrative Motor vehicle crashes are the leading cause of unintentional morbidity and mortality among children in the United States and a leading cause of brain injury. A total of 2,590 children aged 12 years or younger died as a result of unintentional motor vehicle traffic crashes from 2010-13 and hundreds of thousands more were injured. We aim to develop a significantly easier-to-use single-step harness system that improves child safety seats and better protects children riding in motor vehicles.